Critical Transition-based Correlation Analysis for Metabolomics

Abstract The metabolome provides a unique window to monitor a system's molecular state as a result of both intrinsic and extrinsic events. Using ultrahigh-performance liquid chromatography (UPLC) high-resolution mass spectrometry (HRMS), the gold standard technology of metabolomics, it is possible to measure hundreds of metabolites in thousands-to-millions of cells to enhance the signal for trace-level compounds. Recent advances in HRMS technology have extended these measurements to also trace-level detection for rare or precious samples, where averaging is not feasible or hinders results interpretation. Despite the availability of high-sensitivity HRMS, a bottleneck in metabolomics is a lack of software tools capable of detecting trace-level signals in the resulting complex metabolomics data. The proposed work fills this technological gap by developing a software suite that surveys HRMS data sets for trace-level signals (Specific Aim 1) and helps find correlations between metabolite variances (Specific Aim 2). The approach stems from manual data processing protocols that have been established and validated for high-sensitivity analyses as well as critical transition models in physics that efficiently indicate transition points in a network. The software is validated using HRMS data sets that have been acquired for differentiating cells in the early developing embryo of the South African clawed frog (Xenopus laevis), a powerful model in cell and developmental studies, and functional experiments that test the developmental significance of select metabolites. The work includes tests designed to ensure the compatibility of the software to HRMS data from broad types of mass spectrometry instrumentation and different types of metabolomics studies, including neuroscience and drug metabolism and data deposited in MetabolomicsWorkbench, a public metabolomics data repository. The final product is metabolomics software that is applicable to broad types of metabolomics investigations. Besides providing new software, the data that are obtained during this work provide new information on metabolomic changes underlying cell differentiation in the developing embryo. The outcomes of the proposed work are matched with the goals of RFA-RM-15-021, “Metabolomics Data Analysis (R03).” The proposed software is scalable to HRMS data from diverse instrument vendors, aids the identification of trace-level metabolite signals, and facilitates the analysis of metabolite- metabolite correlations in the system, which in turn facilitates the design of hypothesis-driven studies to help better understand health.

Public health relevance
Project Narrative High-resolution mass spectrometry is a powerful analytical instrument that is able to measure small molecules, called metabolites, in high detection sensitivity. This work develops new computational approaches to analyze the complex data that result from these trace-level analyses to help better understand basic metabolic processes during normal development and disease.